Ceramide-Induced Destruction in Emphysema

Abstract
A hallmark of emphysema is the net loss of cells that form alveolar units required for gas exchange, due to
increased injury and impaired cell repair caused by inhalation of cigarette smoking (CS). Our proposal will
focus on how to enhance the survival and repair of lung microvascular endothelial cells, which are essential for
the maintenance of the alveolo-capillary membrane. To survive stress, injured cells engage a repair process,
autophagy, characterized by a sequence of steps (flux) devoted to the lysosomal degradation of damaged
proteins and organelles. Despite progress made in linking autophagy with COPD, little is known as to how CS
disrupts autophagic flux and approaches to restore its proper function are lacking. We propose to fill this
knowledge gap, by elucidating the regulation of lysosomal fitness and autophagic flux by sphingolipid
metabolites during homeostasis and CS exposure. We uncovered two sphingolipid rheostats (sphingosine/S1P
and ceramide/glucosylceramide) that control the autophagy flux, but are disturbed by CS. We hypothesize that
restoration of the sphingolipid rheostat is required to complete lysosomal autophagy and repair cigarette
smoke-induced lung microvascular endothelial cell injury and will alleviate emphysema. We will use
complementary approaches of human lung primary endothelial cells in 2D and 3D models of repair, including
co-cultured with alveolar type II epithelial cells, human precision cut lung slices, and mouse models of CS
exposure, to pursue three specific aims. Completion of these aims will fill important knowledge gaps in
emphysema pathogenesis, will mechanistically link targeted metabolomics with functional outcomes, and
provide potential new targets for treatment of emphysema.

Public health relevance
NARRATIVE This proposal is to understand the repair mechanisms of cells that comprise the alveoli, which form gas exchange area of the lung damaged by cigarette smoking. Focusing on bioactive lipids and their metabolic control, we propose experiments to improve the ability of human lung endothelial cells to withstand the irreversible injury and loss from smoking. We designed experiments to test new therapeutic targets to repair the lung in emphysema models which are of clinical significance.